Signal Transduction to P70 S6 Kinase 1

Project Summary. (30 lines)
Cancer is the 2nd leading cause of death in the US. The advent of new treatments such as immunotherapy and
targeted therapies have revolutionized the fight against cancer, and when combined with surgery or chemo-
therapy, often result in positive therapeutic responses. Eventually, however, most tumor cells gain the ability to
resist current therapies, making it critical that we continue to define cancer causing and driving processes to
increase the available arsenal of anti-cancer drugs. Given the role of metabolism and metabolic environments
in cancer progression, understanding these aspects of cancer progression also has the potential to reveal new
classes of cancer drugs that take advantage of cancer-associated signaling and metabolic vulnerabilities. mTOR
complex 1 (mTORC1), is a protein kinase complex that senses various environmental cues and coordinates
anabolic and catabolic processes to regulate cellular homeostasis. mTORC1 becomes activated when amino
acids, lipids, energy sources, oxygen and growth factor levels are sufficient. Different cancer cell-associated
mutations provide tumor cells with the ability to optimize usage of these regulatory components or find ways to
overcome deficiencies in these mTORC1 regulators, including nutrients. Additionally, once activated it is still a
mystery how mTORC1 regulates and coordinates the many processes required to promote cell growth,
proliferation, migration, and survival. To better understand mTORC1 signaling, we have combined our mTORC1
phospho-proteome, proteome, interactome, metabolome and gene expression data sets, to support new
discoveries. In this proposal we have outlined several goals based on these data, our recently published work
and the 35 years experience of my lab, that support our long-term goals of defining mTORC1-S6K1 regulation
and signaling, and for revealing new information to support efforts to kill cancer cells with activated mTORC1
signaling. Our discoveries and experience are now driving us to; (i) determine how nuclear accumulation of
GSK3, upon suppression of mTORC1 signaling, regulates chromatin remodeling and DNA damage repair,
nuclear events linked to biological processes altered in cancer cells, (ii) characterize a novel S6K1 effector
kinase, SRPK2, and its role in mRNA biogenesis of interferon-stimulated genes and its role in therapy resistance
and (iii) define a new link between essential dietary ω-6 and ω-3 fatty acids and mTORC1 activation, highlighting
a potential dietary intervention as part of a treatment program for mTORC1-driven cancers . In conclusion, there’s
a critical need for a greater understanding of the molecular basis of mTORC1 regulation and signaling, as well
as its links to processes associated with cell growth, metabolism, survival and drug resistance. Our expectations
are that successful completion of the proposed work will impact cancer biology/physiology and therapy through
the identification of new therapeutic targets and biomarkers that can lead to the improve detection and elimination
of cancer cells with unregulated mTORC1 signaling, estimated to occur in 70-80% of all human cancers.

Public health relevance
Project Narrative / Relevance: (3 sentences) We have recently expanded our knowledge of mTORC1 regulation and signaling by taking advantage of various pathway transcriptomics, phosphoproteomics/proteomics, interactomics and metabolomics we have completed to reveal potential mTORC1-regulated biological processes that are previously understudied and critically important in addressing the full potential of mTOR signaling in regulating cancer cell growth and metabolism. These data have led us to make many novel discoveries in the past and now lead us to investigate new areas of mTORC1 regulation and signaling that we are currently focused on defining; (i) how GSK3 nuclear signaling controls cellular metabolism, survival and growth, (ii) how another novel effector of the mTORC1-S6K1 pathway, SRPK2, regulates the expression of interferon-stimulated genes and its impact on therapy resistance and (iii) how essential dietary ω-6and ω-3 fatty acids alter mTORC1 activation and breast cancer These novel aims, which to our knowledge are not being investigated by others, place us in the unique position to uncover and understand at a biochemical and molecular level new regulatory processes, new biomarkers and new potential targets for drug discovery that are needed for personalized therapeutic intervention in many metabolic diseases, such as diabetes, obesity, aging and others, and in this proposal, cancer. progression.